Targeting Nonalcoholic Fatty Liver Disease during the reproductive period to improve women's health outcomes

Metabolic dysfunction associated steatotic liver disease (MASLD), previously known as nonalcoholic fatty liver
disease (NAFLD), and its progressive form, metabolic dysfunction associated steatohepatitis (MASH), is the
leading cause of cirrhosis and liver transplantation in women, yet it is often undiagnosed until overt
complications have developed. Non-invasive tests can now identify “at-risk” MASH, defined as having the
highest risk for liver disease progression. Women of reproductive age commonly engage with healthcare
systems during their pregnancy care, providing a unique opportunity to identify “at-risk” MASH early,
particularly because metabolic changes in pregnancy may initiate and/ or worsen MASLD progression. As
such, we first conducted a multidisciplinary protocol to screen for MASLD in pregnant individuals, Fatty Liver in
Pregnancy (FLIP) I, in which we identified 1) a 14% overall prevalence of MASLD in pregnant individuals, 2)
Hispanic ethnicity and pre-pregnancy weight as key predictors of MASLD in pregnancy, and 3) in a pilot study
of postpartum assessment, found that 83% of individuals had worsening MASLD grade post-delivery. Given
that hepatic lipid metabolism dysregulation plays a central role in MASLD initiation and progression, in a
preliminary lipidomics analysis in FLIP I participants, we identified distinct lipidomic profiles in individuals with
MASLD in pregnancy (compared to non-pregnant individuals with MASLD), and clustering of polyunsaturated
fatty acid-derived oxidized fatty acids in individuals with MASLD, gestational hypertension and preeclampsia,
emphasizing the potential shared role of these lipid pathways in the pathogenesis of MASLD and these
adverse pregnancy outcomes (APOs). With our findings from FLIP I, we are now poised to study the
longitudinal influence of MASLD in pregnancy, and associated lipid parameters, on women's health. In the
proposed FLIP II study, we seek to evaluate the evolution of MASLD in pregnancy and its influence on
pregnancy outcomes, identify predictors for the development of “at-risk” MASH after pregnancy, and evaluate
the MASLD driven lipid based mechanisms that predict these events. We will prospectively screen 1540
pregnant individuals for MASLD (by ultrasound and Fibroscan) in early pregnancy and enroll them for
longitudinal follow up for up to one year postpartum. We will administer detailed questionnaires collecting
sociodemographic, dietary, and clinical data and collect and bank serum specimens for analysis. Our specific
aims are 1) To determine the association between MASLD in pregnancy and APOs; 2) To evaluate antepartum
factors that predispose to “at-risk” MASH post-pregnancy; and 3) To investigate the lipidomics-based
mechanisms underlying MASLD in pregnancy and its association with post-delivery “at-risk” MASH. By
uncovering novel insights into the natural history of MAFLD/ MASH in women in the pregnancy/ postpartum
period, our study will help stratify risk factors for MASH progression and provide valuable information for future
targeted interventions in this subgroup. Ultimately, this research will enhance our understanding of how
MAFLD influences both the course of pregnancy and the subsequent progression of maternal liver disease.

Public health relevance
Metabolic Dysfunction Associated Steatotic Liver Disease (MASLD) is a leading cause for cirrhosis and liver transplantation in women, and there is an urgent need to identify metabolic dysfunction associated steatotohepatitis (MASH), its progressive form, before complications have developed. Pregnancyis an opportunity to diagnose, risk-stratify, and intervene before disease progression. This project will prospectively evaluate the association of MASLD diagnosed in pregnancy with adverse pregnancy outcomes, identify individuals with “at-risk” MASH in the post-pregnancy period, and investigate the MASLD associated lipid-mediated mechanisms that predict these outcomes.